Activating Low-Affinity T Cells to Prevent Relapse in Acute Lymphoblastic Leukemia

PROJECT SUMMARY/ABSTRACT
Acute Lymphoblastic Leukemia (ALL) is the most common form of childhood cancer. Despite dramatic
improvements in initial remission rates over the past 50 years, relapsed ALL remains a significant challenge
and is the second leading cause of cancer-related death in children. Thus, ALL continues to pose a substantial
health concern. The BCR-ABL fusion protein, resulting from a chromosomal translocation, is a key driver of
leukemogenesis in ALL and serves as a promising target for immunotherapy due to its tumor-specific and
essential role in oncogenesis. Studies have indicated that the presence of T cells specific for the BCR-ABL
fusion epitope correlates with better leukemia control; however, vaccine-based strategies to elicit such
protective T cell responses have not been successful. Our lab, together with our collaborator, has previously
generated MHC class II tetramers linked to the BCR-ABL fusion peptide (BAp), which identified a small
population of CD4+ T cells capable of recognizing this leukemia antigen. These BAp CD4+ T cells expanded in
the presence of BCR-ABL+ leukemia but were often converted into immunosuppressive FOXP3⁺ regulatory T
cells (Tregs) or dysfunctional type 1 regulatory (Tr1) like cells producing IL-10, limiting their effectiveness.
Interestingly, combining tyrosine kinase inhibitors like nilotinib with anti-PD-L1 antibodies promoted Th1 CD4+
T cell responses and prevented relapse in murine models, suggesting that effective activation of BAp-specific T
cells can enhance leukemia control. A key question that emerges is how to identify and activate T cells capable
of sustaining durable anti-leukemia responses without succumbing to exhaustion or immunosuppressive
conversion. We have collaborated with Dr. Dileepan to develop "affinity-enhanced" peptide-MHC class II
tetramers (BAp) by augmenting the interaction between the MHCII β chain and the CD4 co-receptor, allowing
us to identify and potentially activate these low-affinity T cells. I propose that activating low-affinity BAp-specific
T cells using these affinity-enhanced reagents can generate potent and sustained anti-leukemia immunity.
Thus, my central hypothesis is that a proper activation of low-affinity BAp CD4+ T cells is crucial for preventing
relapse in ALL. This hypothesis will be tested in the following two specific aims: (1) Determine whether
enhancing low-affinity BCR-ABL-specific T cell responses limits relapse, and (2) Determine the
relationship between functional low-affinity BCR-ABL-specific T cells and clinical outcomes in ALL
patients. Completion of these aims will further advance our understanding of how low-affinity T cells can be
harnessed to generate durable anti-leukemia responses and how perturbation of these responses can lead to
relapse in ALL. This research may lead to new immunotherapeutic strategies that improve survival outcomes
for ALL patients and provide insights applicable to other cancers. Finally, this project will provide me with
important training in the use of cutting-edge research tools and models, which are important skills for me to
acquire as I embark on a career as a physician-scientist focused on cancer immunotherapy.

Public health relevance
Project Narrative Acute Lymphoblastic Leukemia (ALL) is the most common childhood cancer, with relapse remaining a significant cause of mortality. The BCR-ABL fusion protein drives leukemogenesis in ALL, but current therapies often fail to sustain effective immune responses due to T cell exhaustion and immunosuppression. The proposed studies will elucidate whether activating low-affinity T cells specific to the BCR-ABL fusion peptide can generate durable anti-leukemia immunity, potentially reducing relapse rates.